The Role of the Locus Coeruleus-Norepinephrine System in Flexible Decision-Making

PROJECT SUMMARY/ABSTRACT
Flexible decision making, in which individuals adapt their decision strategies, is a hallmark of human
cognition. In particular, humans are able to shift between impulsive (fast, but inaccurate) and deliberative
(accurate, but slow) strategies based on situational demands. Observations that this capacity is disrupted in
neuropsychiatric disorders motivates the study of the neural mechanisms that regulate this type of flexible
decision making. Previous studies suggest that locus-coeruleus norepinephrine (LC-NE) system may play a key
role in flexibly switching between impulsive and deliberative decision making. However, we still lack a precise,
circuit-level understanding of how the NE-LC system alters information processing in downstream targets to
effect decision making.
To address this gap in knowledge, we propose to utilize a rat model of flexible decision making to identify
how NE-LC alters information processing during flexible decision making. Specifically, we aim to test predictions
of a leading computational model, the adaptive gain theory model, which posits that high NE tone alters the gain
of information processing in neurons of the cerebral cortex leading to impulsive decision making. Our proposal
is separated into three aims. In the first aim, we will use cellular resolution imaging of LC-NE activity and NE
release to determine whether changes in NE signaling correlate with changes in impulsivity as organisms
respond to environmental demands. In the second aim, we will manipulate the activity of NE neurons in the LC
using chemogenics and evaluate whether artificial activation and silencing of LC-NE system is sufficient to drive
changes in impulsivity. In the third aim, we will use simultaneous imaging of neuronal dynamics and NE release
to determine whether NE tone predicts the strength of cortical responses to decision-related sensory inputs. If
successful, this project will achieve a circuit-level understanding of how NE signaling regulates flexible discission
making. This improved understanding will provide a critical advance in identifying the neural mechanism of
decision making and will provide a foundation for understanding how these mechanisms may be affected in
neuropsychiatric disorders.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because our ability to diagnose and treat mental illness depends on our understanding of how the nervous system processes information related to complex behaviors. The research described in this proposal will establish a new system to study how the norepinephrine system alters information processing in the cerebral cortex and how these changes effect decision making. If successful, this work will uncover basic principles of how decision related signals are processed by cortical circuits and how noradrenaline signaling flexibly alters cognition.